Computational tools to study relationships between sequence, structure, and function in lncRNAs

Abstract: Long non-coding RNAs (lncRNAs) are transcripts longer than 500 nucleotides that do not encode
proteins and have been shown to have important roles in the cell, including gene regulation. Nevertheless, most
lncRNAs are functionally uncharacterized, and identifying their functions remains a priority in human genomics.
Two major impediments slow the discovery of regulatory functions in lncRNAs: (1) sequence ambiguities for
expressed lncRNAs determined from short-read RNA-seq data and (2) knowledge gaps regarding which physical
properties, including RNA structure, bestow regulatory function. LncRNAs are known to be spliced inefficiently,
yet transcript annotation databases and RNA-seq abundance estimators typically do not consider intron-
containing transcripts in their calculations, causing researchers to inadvertently ignore potentially functional
lncRNA isoforms. Additionally, although structure is universally important for RNA function, there is a lack of
means to identify and compare structural patterns across the transcriptome, hindering the study of the role of
structure in lncRNAs. In this proposal, I will develop computational approaches that will enable researchers to
(1) evaluate the empirical support for transcripts across annotated lncRNA loci to identify the most relevant
lncRNA sequences for further study and (2) identify recurring patterns in the secondary structures of transcripts.
I will apply these approaches to identify lncRNA transcripts associated with disease in GTEx and identify
structural properties associated with specific protein-binding events in lncRNAs. My research will improve
lncRNA research by ascertaining lncRNA expression, rigorously evaluating support for all transcripts, including
intron-containing transcripts, and bettering our understanding of the role of structure in lncRNA functions by
enabling analysis of structural patterns across the transcriptome.
My long-term goal is to become a bioinformatician for an RNA drug discovery company where I can
computationally identify drug targets and transcripts that can modulate critical cellular processes in humans. At
the University of North Carolina at Chapel Hill (UNC-Chapel Hill), I have been conducting research in the
Calabrese lab under the mentorship of Dr. Mauro Calabrese and Dr. Alain Laederach to become an independent
researcher with strong skills relevant to RNA bioinformatics. The labs of my co-mentors are extremely
collaborative and have expertise in diverse and complementary areas that are well-suited to my career goals.
Under this fellowship, I will undergo extensive training in RNA biology, genomics, and bioinformatics through
mentored research, as well as by attending conferences, symposiums, seminars, and classes. I will also gain
experience in mentorship, leadership, and communication through resources provided at UNC-Chapel Hill and
other local institutions. I will apply these skills in my research as well as in an internship with a local RNA drug
discovery company. The experiences under this fellowship will enhance my ability to successfully transition and
contribute to RNA drug discovery through computational bioinformatics.

Public health relevance
PROJECT NARRATIVE There are thousands of long non-coding RNAs (lncRNAs) present in human cells, however, we only know what a few do. LncRNAs have been connected with human health concerns including autoimmune diseases, cancers, and cardiac issues, so determining their cellular roles is critical for advancing our understanding of disease. The goal of my research is to develop computational tools that further our knowledge of the roles lncRNAs play in cells and increase the accuracy of RNA research.